UNDERGRADUATE FELLOWS PROGRAM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. There are 38 undergraduate fellows from our partner institutions who either do research at an undergraduate institution or at the lead research intensive institution generally through the summer. Funding for the students and some support for the research in the mentor's laboratory comes out of the contracts to the partners but the overall running of the program, the compliance training at the beginning of the summer, the convocation at the end of the summer to introduce post-baccalaureate opportunities and be honored at a poster presentation, and other group opportunities are supported by the administrative core.